Harmonizing multi-site diffusion MRI acquisitions for neuroscientific analysis across ages and brain disorders

Abstract(
!
Diffusion MRI (dMRI) is the only non-invasive method that can map the living human brain’s connections and is
critical for understanding mental disorders. Several large studies such as the Human Connectome Project (HCP)
and the Adolescent Brain Cognitive Development (ABCD) have collected or are poised to collect diffusion MRI
data from over 30,000 subjects. However, an important challenge is that these datasets collected from different
scanners cannot be pooled for joint analysis due to large inter-scanner (inter-site) differences, caused by
differences in vendor specific software for data reconstruction, the sensitivity of head coils etc. These scanner
differences are often larger than the effect sizes observed between groups in psychiatric disorders. A second
challenge for large-scale data analysis is the lack of a single consistent ontology-based definition and automated
extraction of white matter connections across the lifespan (including neonates and children). A third challenge is
the sheer size of the combined dMRI datasets (several terabytes), limiting the ability of researchers to test
hypotheses as this requires expertise and complex computational resources for processing, storing, and
visualizing such large volumes of data. In this grant, we propose to address these challenges to enable large-
scale data-intensive analysis of dMRI data. Specifically, in Aim 1, we propose to develop novel mathematical
algorithms to remove scanner-specific differences from data acquired at multiple sites. We will harmonize 10,000
subjects from the ABCD study acquired at 21 different sites, another 10,000 subjects from the HCP initiative
spanning the entire lifespan and numerous disease indications and 10,000 subjects from the Healthy Brain
Network. All the harmonized datasets (30,000 subjects), will be shared with the community using the NIMH data
archive (NDA). In Aim 2, we will develop a formal ontology-based system for defining 189 white matter fascicles
using neuroanatomical landmarks known from human and monkey literature on brain connectivity. Our main
focus will be to develop novel algorithms for automated and consistent clustering and extraction of these fiber
bundles spanning the entire human lifespan including neonates. To enable widespread use without the need for
demanding computational resources and technical knowledge, in Aim 3, we will develop a web-based system
for real-time 3D viewing and querying of the harmonized data and fascicles (integrating with NIMH data archive
infrastructure) for a user-defined selection of subjects from the entire cohort of subjects across different
diagnostic categories. Overall, the potential impact of this framework is significant, as it will, for the first time,
allow a large-scale data-intensive analysis of dMRI data to study neurodevelopment as well as mental disorders
cutting across diagnostic boundaries.
!

Public health relevance
Narrative( Diffusion MRI (dMRI) is the only non-invasive method that can map the living human brain’s connections and is critical for understanding all brain disorders. Neuroimaging studies from a multitude of sites all over the world are collecting a huge repository of dMRI brain imaging data, but several barriers currently impede large-scale dMRI data analysis, including sensitivity to inter-scanner differences and the lack of a single comprehensive dictionary of white matter fascicles defined for the entire brain. The novel tools proposed in this grant will enable joint large-scale analysis of dMRI brain imaging data (30000+ subjects) for the first time, improving our understanding of the human brain in health and disease.